Administrative Core

The Administrative Core will provide oversight and coordination for the PPG projects and cores which encompass investigators from 4 research universities, 3 teaching hospitals, several institutes and multiple academic departments. This core will serve five purposes: C.I. standard administrative support, C.2. scientific oversight, C.3. biostatistical and data management support, C.4. biomedical ethics oversight and consultation and 0.5. gene medicine regulatory compliance. This core will serve projects 1-5 and cores A and B.